Addressing Protein Synthesis Regulation within Small Numbers of Discrete Neurons

Project Summary/Abstract
Transcription dominates the gene expression landscape of circadian rhythms and a number of neuroscience
areas. Yet post-transcriptional regulation, including translational regulation and the role of RNA binding
proteins (RBPs), has become increasingly recognized as important in recent years. Moreover, understanding
the roles of RBPs in diverse cell types and diseases and ultimately therapeutic intervention requires identifying
the RNA targets of RBPs. The ribosome can be considered a RBP, so this focus on post-transcriptional
regulation and RBP targets includes identifying ribosome-associated transcripts, namely RNAs that change
their translational status under defined circumstances. RBP identification is particularly challenging from small
numbers of cells, e.g., cancer stem cells within a large, heterogeneous solid tumor or discrete neuronal
subtypes. These settings preclude traditional biochemistry and therefore require new approaches. Two new
methods recently appeared, TRIBE and STAMP, which exploit the RNA editing enzymes ADAR and APOBEC,
respectively. Their ribosome versions, Ribo-STAMP and Ribo-TRIBE, are even more recent and fuse a
ribosomal protein to the editing enzymes. This is so that the enzyme will be near RNAs that are being
translated and will “mark” them by changing their sequence. These edits are identified by mRNA sequencing
and straightforward computational methods, even from single cells. We propose to compare Ribo-STAMP and
Ribo-TRIBE side-by-side in mammalian cell culture systems, to assess their efficacy and to determine the
optimal configuration of ribosome-editing enzyme fusions. We also propose to develop Ribo-TRIBE for use in
Drosophila; we recently discovered that STAMP does not work in this organism, which limits us to TRIBE. We
will then extend these methods to the more biological context of neurons, from Drosophila as well as from
mouse brains. To complement these efforts, we will develop an extension of the TRIBE/STAMP theme called
Nanobody-editing. It consists of fusing the editing enzyme, ADAR or APOBEC, to a GFP-nanobody, which will
then deliver the editing enzyme to any GFP-tagged RNA binding protein or GFP-tagged ribosome. The
chimeric, recombinant protein will be used in vitro as a recombinant protein or expressed in vivo. Nanobody-
editing will facilitate identifying RBP and ribosome targets, because already existing GFP-tagged RBP or
ribosomes can serve as substrates. Moreover, in vitro editing will in many cases obviate the need to generate
new transgenes and transgenic animals. Lastly, TRIBE and as well as Ribo-TRIBE will be used to characterize
translational regulation “around the clock” within a few key Drosophila circadian neurons. These efforts will
deepen our understanding of circadian gene expression regulation as well as provide the community with new
tools with which to study translation in important but challenging biological systems.

Public health relevance
Project Narrative RNA-binding proteins (RBPs) and ribosomes are key molecules that drive and regulate post- transcriptional gene expression. RBPs are implicated in many different diseases including cancer and brain and neurodegenerative diseases (Fragile X syndrome, ALS). Ribosome-based genetic tools such as Ribo-TRIBE, Ribo-STAMP and Nanobody-editing will enable different areas of biology and medicine to address gene expression regulation within very small numbers of specific cells or neurons.